Core Vision Grant - Functional Imaging

Abstract
The Functional Imaging Module supports vision research in the Center for Brain Imaging at New York
University. CBI is a shared research center for research and teaching in visual and cognitive neuroscience at
NYU. CBI is located on the ground and second floors of the same building that houses most of the vision core
faculty, and houses facilities for MRI, MEG, EEG, and TMS. The CBI is now in its sixteenth full year of
operation, and members of the Core faculty are among its most active users.
The Functional Imaging Module will enable NEI grantees and other vision researchers to develop, implement,
and maintain technical advances, to benefit from specialized tools developed and used by individual labs, to
use and contribute to a database of human research subjects with extensive vision-related brain and
behavioral measures, to standardize and improve image processing pipelines, to support MRI-compatible
TMS, to facilitate the public sharing of data, to develop shared software for acquisition and processing of
monkey MRI data (structural, diffusion, and functional), and to develop software to integrate data acquired
through the multiple measurement modalities available at the Center for Brain Imaging. The module will
leverage research support by stimulating collaborative research between members of the Core faculty, and by
facilitating sharing techniques and instrumentation between members of the Core faculty. If requested, the
technical developments will also be shared with vision scientists at other institutions.
The Functional Imaging Module provides moderate or extensive support for 16 members of the Vision Core,
including two young investigators and 10 NEI funded investigators who hold qualifying grants.